IGF::CL::IGF:INFINITY CONFERENCE GROUP INC:1108883 [17-004800] Conference meeting administration and planning for the 12th Annual Pain Consortium

Conference meeting administration and planning for the 12th Annual Pain Consortium